Scripps Center for Oceans and Human HealthAdministrative Core

Administrative Core Summary
The Administrative Core for the Scripps Center for Oceans and Human Health (SCOHH) will be
managed out of Scripps Institution of Oceanography (SIO) at UC San Diego. The Center will be
under the leadership of Drs. Bradley Moore, Skaggs School of Pharmacy and Pharmaceutical
Sciences and SIO, and Amro Hamdoun, SIO. Director Moore will oversee the administrative
requirements of SCOHH, provide work direction for center staff, and ensure that frequent and
substantive communication occurs across the research projects and cores, while Co-Director
Hamdoun will assist Dr. Moore and take the lead in interfacing with the Community Engagement
Core (CEC). Drs. Moore and Hamdoun will be supported by an internal steering committee
comprised of the other six project and core leaders. SCOHH will also have an External Advisory
Committee (EAC) comprised of 3-5 members with expertise in each research and outreach area
along with representation from the community as well as the health department. The EAC will
function to assist in evaluating the impact, synergy, and progress of the three projects, the CEC,
and the Administrative Core. We plan to host annual EAC meetings both in-person (years 1 and
3) and virtually (years 2, 4, and 5), and will schedule the first in-person EAC meeting to coincide
with the COHH4 grantees annual meeting at SIO. The Scripps Center for Oceans and Human
Health will benefit from a dedicated business manager at 50% effort who will be responsible for
the day-to-day functioning of the Center. SCOHH will also be supported by the administrative
infrastructure already in place at SIO, including a business office well versed in NIH/NSF awards,
and access to central departments such as Communications, Government Relations, Foundation
Relations, and Innovation and Commercialization.